Defining Environmental Influence on RNA Processing

Ribonucleases modulate the cellular response to our environment by driving RNA turnover across diverse
RNA metabolic pathways; yet, our limited understanding of the molecular networks linking RNA
processing to environmental stress hinders our knowledge of how these critical responses promote cell
fitness and survival. The long-term goal of my research is to define how the environment exacerbates the
activity of human disease associated RNA processing factors. Mitochondria are central for stress
adaptation and undergo dynamic alterations in RNA processing during environmental changes. As the
powerhouse of the cell, the mitochondria supplies the necessary fuel for stress adaptation. PNPase plays
a central role in mitochondrial homeostasis, but the underlying molecular mechanism regulating its
function remains a mystery. The PNPase exoribonuclease associates with the SUV3 helicase to form the
mitochondrial RNA degradosome, which orchestrates mitochondrial RNA decay. PNPase is a metabolic
sensor that fine-tunes RNA degradosome activity with the metabolic state of the cell through an unknown
mechanism. The central hypothesis of this proposal is that RNA processing plays vital roles in the cellular
response to our environment. The rationale for this project is that uncovering the molecular basis for
stress-responsive RNA processing complexes will provide a novel framework to understand how the
environment impacts critical RNA processing events. This proposal will study (1) How the mitochondrial
RNA degradosome syncs RNA turnover with the metabolic state of the cell and (2) How the RNA
degradosome recognize its RNA substrates for mitochondrial RNA surveillance. To achieve these goals, a
multi-disciplinary program that includes hybrid structural biology, biochemistry, cell biology, and molecular
biology will be implemented to understand the regulation and function of the RNA degradosome in
response to environmental stress and stimuli.

Public health relevance
This work is significant because it will shed light on the relationship between the environment and the severity of PNPase linked Neurological Diseases. Moreover, mitochondrial dysfunction is the hallmark for a wide breadth of pathologies including diabetes, neurodegenerative disease, bipolar disorder, and heart failure. A clear understanding of PNPase function and regulation will be necessary to achieve the therapeutic potential of the environment-responsive PNPase in disease management and treatment.